Social Media Use and Mechanisms of Suicide Risk in Adolescents

Project Summary/Abstract
Suicide rates have nearly doubled among adolescent girls over the past decade. During this same time period,
social media sites (e.g., Instagram, Snapchat, Facebook) have become ubiquitous, with nearly 97% of youth
now using social media. Social media offers both risks and benefits for adolescent development. However,
there is likely a vulnerable subset of youth for whom social media use influences suicidal thoughts and
behaviors (STBs). The primary goal of this study is to examine how and for whom social media use contributes
risk for STBs, so that we may better identify and intervene with youth most at risk. A multi-method approach,
integrating computational psychiatry and experimental techniques, will be used to investigate the specific
mechanisms by which social media use affects STBs. Data will be collected from both an existing dataset (n ~
2,000) and a recruited sample (n = 90 adolescent females, ages 14-17, with lifetime history of STBs). To
identify specific, directly observable social media experiences that heighten risk for STBs, digital trace data
(i.e., social media content and meta-data) will be collected directly from adolescents’ social media pages and
analyzed using machine learning techniques. In addition, an innovative laboratory paradigm with eye-
tracking/pupillometry will be used to examine cognitive and affective responses to social media use that
increase vulnerability to STBs. Participant STBs will be assessed at baseline, 3-month-, and 6-month follow
ups. The aims of the study are well-aligned with the candidate’s long-term career goal of becoming an
independent investigator of adolescent social media use and mental health. To purse this research agenda
going forward, the candidate proposes training in four key areas: (1) machine learning methods for analyzing
digital trace data, (2) experimental eye tracking/pupillometry paradigms, (3) mechanism-based translational
research in adolescent suicide risk, and (4) professional development, with an emphasis on training in effective
interdisciplinary collaboration and the ethics of social media research. A team of mentors and consultants from
multiple disciplines will facilitate the candidate’s training, including experts in youth suicide risk, machine
learning and natural language processing, and experimental peer interaction paradigms. The diverse
resources available at Brown University and Rhode Island Hospital will ensure successful completion of the
project and foster the development of the candidate’s research program. The proposed study has the potential
to contribute significantly to our understanding of the role of social media in adolescent suicide risk. Completion
of the proposed research and training goals will uniquely position the candidate to become a leader in the field
of adolescent social media use.

Public health relevance
Project Narrative Nearly all adolescents use social media sites, yet for a vulnerable subset of teens, social media use may increase risk for suicide. Given rising suicide rates among adolescent girls in recent years, it is critical to examine the reasons why social media use may be related to suicidal thoughts and attempts. Findings of this study will have the potential to inform future suicide intervention and prevention efforts that address the unique needs of adolescents in the digital age.